Administrative Core

The Administrative Core will provide overall logistical and financial coordination of the Program Project. The staff of the Administrative Core will organize all of the monthly, quarterly, and annual review meetings and will foster communication between the Executive Committee and all other Investigators in the Program. The Executive Committee, led by the PI and composed of all Project and Core Leaders, will be responsible for the day-to-day handling of the Projects and decisions regarding minor modifications of the Program direction. The Administrative Core will support the salary of the specialized physician to carry out the euglycemic-hyperinsulinemic clamps that are an integral component of Projects 1 and 2, and will support the salary of the subject recruiter who will recruit the human subjects to be studied in Projects 1 and 2. Finally, the Administrative Core will ensure data security, storage, access, and integration among the Projects and Cores, and will assist all Project and Core Leaders in meeting their Data Sharing obligations when the Projects are complete. All Projects and Cores will utilize this Core.

Public health relevance
The Administrative Core will provide overall logistical and financial coordination of the Program Project, supporting all Projects and the other Cores.